Mechanisms coordinating cell behaviors within tissues during development

PROJECT SUMMARY/ABSTRACT
The formation of functional tissue architectures during embryonic development depends on the ability
of cells to orchestrate collective tissue-level movements. The goal of my research program is to
understand how cells work together to collectively generate the shape and structure of multicellular
tissues in the process of morphogenesis. Our current understanding of morphogenesis has been limited
by conceptual and technological barriers to dissecting the mechanical and molecular inputs that
together coordinate cell behaviors. During this award, we will address these challenges and focus on
resolving several key gaps in our understanding by: (1) analyzing mechanisms by which individual cell
activities are coordinated across tissues to give rise to coherent tissue behavior, (2) elucidating how
activities of the apical and basal sides of cells are coordinated, and (3) uncovering how mechanical
cues coordinate cell and tissue behaviors in distant regions of embryos. Using the model organism
Drosophila melanogaster, we are taking innovative approaches to address these questions in the
context of epithelial tissue morphogenesis. To enable us to dissect mechanisms that coordinate cell
behaviors, we are developing and using new technologies for controlling and quantifying the cell
machineries and forces that drive these cell behaviors. These techniques will allow us to dissect the
molecular and mechanical mechanisms that coordinate cell behaviors within multicellular tissues. This
work will provide a foundation for integrating mechanics into our understanding of how genetic and
biochemical factors control development and may motivate new strategies for controlling tissue shape
and structure in vivo and in vitro. More broadly, the tools and framework we develop will enable us to
investigate the mechanisms that coordinate cell behaviors in a broad range of multicellular processes.
A better understanding of the mechanisms underlying collective cell behaviors can elucidate general
principles of self-organization in biological systems, provide insight into how improper regulation of
these processes leads to human disease, and develop new approaches to manipulate these processes
for therapeutic benefit.

Public health relevance
PROJECT NARRATIVE Functional tissues and organs are generated during embryonic development by the movements and behaviors of cells. The work we propose will greatly enhance our understanding of how individual cell behaviors are coordinated to help generate complex tissue structure. Because the basic cell biological mechanisms are highly conserved, this work will shed light on how improper regulation of these processes results in disease states such as birth defects and cancer and may enable new therapeutic strategies.